Digital detection of handwriting impairments in patients with atypical Alzheimer’s disease and frontotemporal dementia

PROJECT SUMMARY/ABSTRACT
Patients with neurodegenerative disease and dementia frequently report difficulties writing in their daily lives as
an early symptom, and clinical observations suggest that this may be a valuable tool to support differential
diagnosis. Nevertheless, the reported challenges often go overlooked by clinicians who do not have the
domain expertise to recognize their relevance or identify their etiology. Empirically, written language production
is vastly understudied in these populations, particularly when compared to auditory language and speech
production, which also limits the clinical utility at present. We propose that using digital tools to collect and
characterize handwriting samples could increase access for timely and accurate dementia diagnoses,
particularly for those patients who do not have access to the costly neuroimaging and multidisciplinary
expertise that are currently required. Accurate diagnoses are paramount for tailoring prognosis and access to
increasingly available disease modifying drugs.
Before digital handwriting analysis can inform timely and accurate dementia diagnoses or prognosis, it is
crucial to characterize the handwriting patterns specific to each of the atypical Alzheimer’s disease (AD) and
frontotemporal lobar degeneration (FTLD) variants. Prior dementia research has focused on linguistic
knowledge by examining spelling errors or on singular aspects of fine motor skill in specific groups (e.g.,
micrographia in Parkinson’s disease). Exploiting informative elements of handwriting samples requires more
comprehensive analysis of the writing process and the written product and direct comparison of handwriting
across dementia phenotypes. Writing process variables (e.g., stroke speed) are those extracted during the
physical act of writing and must be collected using a digitizing tablet or similar tool. Written product variables
(e.g., letter size and spacing) can be extracted from any written sample. This proposal seeks support for the
technology, personnel, and statistical support to 1) retrospectively analyze longitudinal changes in written
product variables, derived from descriptions of the Western Aphasia Battery picnic scene from a cohort of 90
patients with primary progressive apraxia of speech or agrammatic primary progressive aphasia
(PPAOS/agPPA) and 40 healthy controls, with at least two annual visits and 2) characterize the written product
and writing process in the same task performed on a digitizing tablet in a prospective cohort of 80 patients
with atypical AD and FTLD phenotypes (20 each: posterior cortical atrophy, logopenic primary progressive
aphasia, PPAOS/agPPA, and semantic dementia) and 60 healthy controls. Achieving these aims would be a
foundational step toward developing a digital marker of neurological impairment across AD and FTLD
phenotypes, paving the way for earlier, accurate diagnoses in a highly cost-effective and accessible way.

Public health relevance
PROJECT NARRATIVE/LAY SUMMARY Communication is multimodal, yet the investigation of language and communication in patients with neurodegenerative diseases and dementia is heavily skewed toward listening and speaking. Using a written picture description, we plan to evaluate the writing patterns of a retrospective cohort (Aim 1) of 90 patients with nonfluent/agrammatic primary progressive aphasia and apraxia of speech and 40 controls; and prospectively study (Aim 2) the writing patterns of 80 patients with atypical Alzheimer’s disease and related dementias (i.e., posterior cortical atrophy, logopenic primary progressive aphasia, agrammatic primary progressive aphasia and apraxia of speech, and semantic dementia) who have difficulty with different components of the physical act of writing, comparing them to another group of 60 healthy controls. Data for Aim 2 will be collected on a digitizing tablet to quantify the process of writing (e.g., speed and pressure) as well as the written product (e.g., size and spacing) to offer support for differential diagnosis and, ultimately, prognosis for these patient groups.